Enabling temporal and spatial restriction of MYT1L to identify molecular and postnatal circuit-level druggable targets

Project Summary
Putative loss of function mutations in the MTY1L gene lead to a newly defined intellectual and developmental
syndrome, yet the neurobiological mechanisms underlying this relationship remain unknown. MYT1L Syndrome
is characterized by global developmental delay (particularly in motor and language development), intellectual
disability, highly penetrant obesity and hypotonia, and a significant subset with autism spectrum disorder and/or
attention-deficit/hyperactivity disorder. Other symptoms of variable penetrance include epilepsy, microcephaly,
white-matter thinning, and neuroendocrine disruptions. Thus far, about 100 patients have been described
clinically and prevalence estimates are ~1:2000. However, the function of MYT1L has just begun to be studied,
therefore, we currently know very little about how MYT1L loss of function mutations result in disease. We recently
developed the first MYT1L haploinsufficient mouse model, which successfully recapitulated many of the patient
phenotypes, including hyperactivity, changes in communicative behavior, social behavior challenges, muscle
hypotonia, microcephaly, and obesity. We also identified disrupted gene expression, precocious neuronal
differentiation as a mechanism for microcephaly, and failure of transcriptional and chromatin maturation in adults.
Thus, with this model, we enhanced the understanding of MYT1L function and established a preclinical model
of MYT1L Syndrome. However, it is unknown when during development, and where in the brain the disruption
of MYT1L protein leads to each specific clinically-relevant phenotype. This is because we lack the ability to
clearly define the relevant molecular and circuit-level targets of MYT1L, identification of which would enable
studies of potential rescue therapies. To begin to address these holes, we recently generated a MYT1L
conditional model targeting the same exon as our constitutive haploinsufficient model to allow for spatial and
temporal restriction of MYT1L loss. The goal of this project is to validate this tool for temporal and spatial
applications, and to determine the extent to which postnatal MYT1L function is responsible for the phenotypes
observed in adults and identify the genes regulated by MYT1L in the postnatal brain. Such insights will serve to
help define druggable molecular and circuit targets, as well as therapeutic temporal windows for MYT1L
syndrome. In Aim 1, we will validate our new tool for inducing MYT1L loss in a temporally and spatially controlled
manner and for enabling studies of molecular targets for potential therapeutic action. A fundamental question
we must answer to develop therapeutic strategies for this rare disease is if MYT1L loss disrupts
neurodevelopment (i.e, in the embryo) or neuromaintenance (i.e., postnatally, and in adults). In order to address
this question, in Aim 2, we will leverage our new conditional model and inducible Cre-recombinase genetic tools
to induce loss of MYT1L in the postnatal brain, after completion of early neurodevelopment, and determine which
phenotypes are due to the postnatal functions of MYT1L. Ultimately, this tool will guide future studies into
targeted therapies for MYT1L Syndrome, and potentially other related IDDs.

Public health relevance
Project Narrative We are just starting to understand the function of the IDD-associated gene MYT1L thanks to recently developed mouse models of MYT1L haploinsufficiency. However, we do not yet have the tools to understand how its haploinsufficiency leads to the phenotypes associated with the neurodevelopmental syndrome. Here, we will validate a novel conditional knockout mouse model that will allow us to characterize time- cell- and region-specific protein function to illuminate the role of MYT1L in the context of human disease, and, ultimately, identify novel drug targets (cells or downstream molecular pathways) for the treatment of this rare disease.